Advancing Approaches to Identify Young Children at Risk for Post-Discharge Mortality

PROJECT SUMMARY/ABSTRACT
This K23 Mentored Patient-Oriented Research Career Development Award application details a rigorous plan
for training and research activities that will provide critical skills and experience I need to become an
independent investigator with expertise in prognostic research for post-discharge mortality (PDM) among
young children in sub-Saharan Africa. I am an Assistant Professor of Pediatrics and Emergency Medicine at
Emory University School of Medicine, an attending physician at Children’s Healthcare of Atlanta, and a
pediatric research scientist in the Child Health and Mortality Prevention Surveillance (CHAMPS) network. My
K23 training goals are to develop 1) proficiency in advanced methods in prognostic research, risk assessment
tool evaluation, and large data analysis for PDM clinical prediction modeling in sub-Saharan Africa, 2)
expertise in biomarkers of endothelial dysfunction for PDM, and 3) advanced experience in collaborative global
health research. To achieve these goals, I have constructed an expert, multidisciplinary team of mentors,
advisors, and collaborators. My co-primary mentors are Claudia R. Morris, MD and Cynthia G. Whitney, MD,
MPH. Dr. Morris is a Professor of Pediatrics and Emergency Medicine at Emory University School of Medicine
and an expert in the role of arginine dysregulation in endothelial dysfunction. Dr. Whitney is a Professor of
Global Health at Emory Rollins School of Public Health, the PI of CHAMPS, and an expert in childhood
mortality surveillance in sub-Saharan Africa. My mentor Rishikesan Kamaleswaran, PhD, MSc is an Associate
Professor of Biomedical Informatics at Emory and will mentor me through the development machine learning
risk assessment tools for PDM. PDM rates among young children in sub-Saharan Africa are 3-18% within
months of hospital discharge, far outpacing the 0.1% rate we described in US children. Despite this immense
disparity, there are no implemented risk assessment tools to identify young children at risk for PDM. The
studies proposed here are designed to test the hypotheses that a machine learning approach to identifying
young children at risk for PDM in Tanzania and Liberia will have greater discriminatory value than logistic
regression models, that our risk assessment tools developed in Tanzania and Liberia will accurately identify
young children in Kenya at risk for PDM, and that a key biomarker of endothelial dysfunction (i.e., the global
arginine bioavailability ratio) will be lower in children who die after hospital discharge than those who survive. I
will use the many resources at Emory University School of Medicine, Emory Rollins School of Public Health,
the CHAMPS network, and the Kenya Medical Research Institute to add these studies to the Bill & Melinda
Gates Foundation supported CHAMPS platform with a focus on the identification of young children at risk for
PDM. These studies, the proposed coursework, and didactics will give me the training, skills, and experience
needed to develop into an independent investigator equipped to conduct future research to reduce PDM.

Public health relevance
PROJECT NARRATIVE Post-hospital discharge mortality rates among young children aged <5 years in sub-Saharan Africa are as high as 3-18%, far outpacing the 0.1% rate we recently described in US children. Despite this immense disparity, there are currently no externally validated or implemented risk assessment tools to identify young children at risk for post-hospital discharge mortality in sub-Saharan Africa. The proposed research will assess the discriminatory ability of machine learning risk assessment tools for post-hospital discharge mortality, includes the first external validation study of risk assessment tools for post-hospital discharge mortality among young children in sub-Saharan Africa, and will elucidate the role of a novel biomarker of endothelial dysfunction to predict post-hospital discharge mortality among young children.